Center for Biospecimen Research and Development Shared Resource

Abstract/Project Summary
Center for Biospecimen Research & Development (CBRD)
The Center for Biospecimen Research and Development (CBRD) was launched in 2015 and
has replaced the BioRepository Center (BRC) shared resource presented at the last CCSG
review on 2012. Under the direction of Andre Moreira, MD, PhD, Director of Surgical Pathology
at NYU Langone Health (NYULH) and a recognized expert in lung pathology and biospecimen
research, CBRD was created to support the increased demand across the NYULH research
enterprise for standardized human biospecimens. CBRD focuses on improving the accessibility
of human biospecimen resources to investigators and increasing institution-wide banking efforts
and capacity. CBRD has implemented a campus-wide universal consent and policy for human
biospecimen collection and storage to ensure regulatory compliance. CBRD provides well-
annotated, high quality biospecimens that foster impactful translational research, thus
guaranteeing the clinical relevance of basic findings. CBRD also supports the rapidly expanding
portfolio of Perlmutter Cancer Center (PCC) investigator initiated clinical trials by facilitating
acquisition, processing and distribution of biospecimens from enrolled patients. All of the
samples collected are linked to clinical information obtained in our electronic medical record,
EPIC. The Specific Aims of CBRD are: Aim 1) To maintain and expand a prospective
Biospecimen Repository of PCC patient samples, as well as maintain and expand its linked
clinicopathological information; Aim 2) To process biospecimens, including by carrying out
nucleic acid extraction and provide specialized Pathology support; Aim 3) To stimulate
collaborations involving the distribution of human biospecimens; and Aim 4) To apply high
quality control that meets national and international standards, as well as governance over
biospecimen utilization.